Administrative Core

The overall goal of the Center for the Study of Adolescent Risk and Resilience (C-StARR) Administrative Core
is to manage an infrastructure that supports innovative research, effective training, and impactful outreach by a
collaborative team of grant-holders and early-career scholars focused on understanding and influencing drug-
related attitudes and behaviors during late adolescence and young adulthood. Under the direction of Dr. Rick
Hoyle, Professor of Psychology and Neuroscience at Duke University, the Core will work to 1) enhance funded
research productivity and quality by Center faculty members, 2) grow the next generation of leading scholars in
self-regulation and substance use, 3) coordinate all activities of the Center, including interactions among the
cores and reporting to NIH, and 4) be a national resource for scholars and policy makers in adolescent self-
regulation and substance use problems. Specific activities that support these goals include review and
monitoring of Center-supported research projects, recruitment of new investigators with interests that align with
the Center’s research focus, and facilitation of communication between Center staff members and researchers
and between Center researchers and relevant practitioners and policy makers. Administrative responsibilities
include budget management, preparation of annual progress reports, seminar planning, and meeting
organization. The Core also includes an external Scientific Advisory Board and the C-StARR Executive
Committee.